Structure, pharmacology and signaling of G protein-coupled receptors (GPCRs) in inflammation

Project Summary
Inflammation is a complex process with many lipid and peptide mediators involved. A large number of these
mediators elicit either pro-inflammatory or pro-resolving effects through the action on G protein-coupled
receptors (GPCRs). My lab is interested in the molecular mechanisms by which pro-inflammatory and pro-
resolving GPCRs sense diverse signaling molecules and transduce chemical signals across the cell membrane
to regulate inflammation. We employ a combination of research approaches in structural biology including cryo-
electron microscopy (cryo-EM), pharmacology, and computational biology. We are also making efforts to develop
novel ligands of those GPCRs as potential new drugs through structure-based approaches. In the last funding
period, we have determined structures of several members of a chemotactic GPCR family including the C5a
receptor (C5aR), the prostaglandin D2 receptor 2 (DP2), and the formylpeptide receptors bound to diverse
agonists or antagonists at different conformational states, which allowed us to define the molecular basis for the
action of several drugs and drug candidates. In the current proposal, we will study the signaling and
pharmacology of three lipid GPCRs that regulate different aspects of inflammation, the chemerin receptor
CMLKR1, GPR32, and GPR84. Both CMLKR1 and GPR32 are closely related to the C5aR, DP2 and FPRs.
They have been shown to respond to resolvins, which are SPMs derived from ω-3 polyunsaturated fatty acids
(PUFAs), to induce the resolution of inflammation. In contrast, GPR84 is a newly characterized pro-inflammatory
GPCR that can be activated by endogenous medium-chain fatty acids (MCFAs) to augment inflammatory
responses and enhance phagocytosis by macrophages. Through a combination of approaches in structural
biology, pharmacology, computational biology, and immunology, we aim to provide a comprehensive molecular
understanding of how diverse lipid, peptide, and synthetic small-molecule ligands act on and regulate the
activities of these three lipid GPCRs. Our studies will exploit unique properties of CMLKR1, GPR32, and GPR84
to address several fundamental issues of GPCR signaling and pharmacology including lipid recognition, receptor
antagonism, allosteric modulation, and biased signaling. Our research strategies developed in this proposal will
be applied to our future research on the structure and pharmacology of other fatty acid receptors (FFARs) in
immunometabolism. We will also develop new agents for these GPCRs as useful pharmacological tools and
potential drugs to control inflammation. The new compounds will serve as the leading compounds for our future
drug development effort through structure-based compound optimization and functional characterization.

Public health relevance
Project Narrative Our research is focused on three lipid GPCRs in inflammation and the resolution of inflammation, which represent promising targets for developing new drugs for many inflammatory disorders. We take a variety of research strategies to elucidate the structural basis for receptor function and develop new agents targeting these receptors as novel pharmacological tools. The discoveries from our research will advance our understanding of inflammation biology and facilitate the development of new drugs for controlling inflammation in numerous diseases.